Instrumentation and Bioengineering Development and Application

Development of unique instrumentation using novel approaches is, in many instances, necessary to the success of biomedical research. Areas of emphasis within our group are summarized below. 1) Energy-driven proton pumps are of major importance for energy transduction in living systems. The respiratory chain of animals, as well as single celled organisms, uses energy released from electron transport to oxygen to form an electrochemical gradient for protons, which is then used to synthesize ATP. In collaboration with Dr. R. Hendler, NHBLI, we have developed optical instrumentation that enables studies on the simple 26000 D, photon-driven, proton pump bacteriorhodopsin (BR) to pinpoint specific molecular transformations that generate the most voltage across the membrane. These studies support the view of the BR photocycle as consisting of two parallel cycles. instead of the single photocycle that is favored by many researchers. Information obtained from this proton pump should help in understanding more complex systems such as mammalian cytochrome oxidase. Combined infra-red and optical spectroscopy has produced kinetic structural information that characterizes each step of the photocycle, and collaborative studies are underway with colleagues at NIST to produce single crystals of BR membrane protein. The ultimate goal of this project is to characterize the BR crystal using similar established approaches in concert with time resolved X-ray diffraction to obtain structural information at the atomic level, thus enabling an understanding of protein conformational changes that result in electrogenic transport of protons across the membrane. We have developed instrumentation to study the optical kinetics of the BR photocycle in approximately 1 microliter samples of membrane fragments. The BR is positioned between two 600 micron fused silica optical fibers, which carry the visible-spectrum monitoring light produced by an Oriel xenon arc lamp, both orthogonal to a third fiber that carries the 532nm photolysing 7ns pulses generated by an Opotek Q-switched Nd-Yag laser second harmonic. The output monitoring fiber carries information on the spectral kinetic changes that occur following the photolysis pulse. These changes are identified by positioning the fiber at the entrance slit of an Acton .25m spectrograph, the output of which is monitored by either a Princeton Instruments CCD camera directly or indirectly after intensification by an Opelco-Videoscope image intensifier. This instrumentation acquires 524 successive spectra at 512 wavelengths in the visible spectrum covering the characteristic BR photocycle changes. The spectral changes in the photocycle are not uniform and comprise events ranging from fast events on the sub-microsecond time scale to slower events with millisecond time scale changes. To accomplish this a staggered time schedule is used with time increments from 5 microseconds to 500 microseconds. Using the CCD directly presents a light limitation at the shorter exposure times, and an image intensifier has been integrated into the system to overcome this limitation and to provide shorter sub-s exposure times. We have spent considerable effort this year overcoming inherent problems associated with both the CCD camera and the image intensifier and are close to an optimal arrangement. We are currently working with a thin film filter manufacturer to produce a spectral smoothing filter that will adjust the spectrum of the monitoring light source such that the CCD output is uniform across the dispersed spectrum enabling electronic gain to be used to raise the signal levels significantly above background. In a parallel effort with colleagues at NIST at the Center for Advance Research in Biotechnology (CARB), in the current year, we have integrated custom fiber optic cables, which we designed and fabricated, to the visible/IR Bruker microscope and significantly improved the output signal that is coupled to an existing custom optical multichannel analyzer that we developed previously. This system will initially evaluate the feasibility of using this approach to study BR membrane crystals that are currently being grown by other colleagues at CARB. We have already been able to collect spectra at an acceptable signal-to-noise ratio with spot sizes of 200 microns - a level that approaches the sub 100 micron size of the expected BR crystals. 2) In a collaboration with Intelligent Material Solutions, Inc., we are investigating the potential use of infra-red upconverting nanocrystals as labeling agents. The advantage of upconverters over typical fluorescent labeling agents is that background fluorescence that limits the lowest level of detection should be virtually zero. In addition, many detectors have very low sensitivity in the infrared, used to excite the upconverters, thus reducing the need for stringent filtering requirements that are usually required to eliminate the excitation light. We are exploring several possible avenues for biological applications of these upconverters, including labeling and therapeutic agents. 3) Together with colleagues from CIT, who designed and fabricated a visual stimulus, optical imaging, and control apparatus to study neural connectivity in fruit flies, we have collaborated with Dr. Chi-Hon Lee, NICHD, to integrate a near-ir laser into the optical path of the apparatus to provide a feedback stimulus to the fruit fly depending on its response to the visual stimulus. Near infrared is needed to prevent the feedback stimulus from being recognized as a visual stimulus by the fruit fly. 4) In collaboration with Dr. Shawn Chen's group, we are exploring the use of near ir laser irradiation to efficiently raise the temperature of nanoparticles that are associated with tumor masses. Temperature effects are assessed through real time infrared imaging.